Lands cycle and skeletal muscle insulin action

Project Summary
Skeletal muscle insulin resistance is an early and fundamental defect in the development of type 2 diabetes.
Molecular mechanisms by which obesity promotes muscle insulin resistance remain incompletely understood,
but multiple lines of evidence suggest aberrant lipid metabolism as a likely contributor. Recently, our laboratory
published findings that accelerated lyso-phospholipid metabolism (Lands cycle) desensitizes skeletal muscle
insulin receptor to promote diabetes. In humans, obesity increased skeletal muscle lyso-phosphatidylcholine
(lyso-PC) acyltransferase-3 (LPCAT3) and decreased lyso-PC concomitant to a decrease in insulin sensitivity.
In mice, genetic or pharmacologic inhibition of LPCAT3 increased lyso-PC and enhanced skeletal muscle and
systemic insulin sensitivity. In this proposal, we will further exploit skeletal muscle Lands cycle to understand
its role in modulating insulin action. We hypothesize that: 1) Lands cycle modulates plasma membrane
microdomain clustering to amplify insulin signaling, 2) pharmacological inhibition of Lands cycle can ameliorate
hyperglycemia in the Zucker Diabetic Fatty rats, and 3) exercise training enhances skeletal muscle insulin
responsiveness by deceleration of Lands cycle.

Public health relevance
Project Narrative Skeletal muscle insulin resistance accounts for ~90% of the reduction in insulin-stimulated glucose clearance in type 2 diabetic individuals. Alteration in lipid metabolism has been implicated for the pathogenesis of muscle insulin resistance, but the exact identify of the lipid-mediated mechanism that suppresses muscle insulin action in humans remains inconclusive. In this proposal, the role of lyso-phospholipids on skeletal muscle insulin sensitivity will be investigated.